Characterizing a novel Plasmodium cytoskeletal protein

Abstract
Plasmodium falciparum is a pathogenic eukaryote in the phylum Apicomplexa with a complex life cycle that
alternates between Anopheles mosquitoes and humans. During the blood stages of the P. falciparum life cycle,
a single merozoite invades a human red blood cell (RBC). Over the course of 48 hours, the parasite multiplies
its genetic material and organelles via schizogony to form 20-36 merozoites. During infection, a small subset of
these parasites (~0.2-1.0%) commit and differentiate into transmissible male and female gametocytes via staged
process called gametocytogenesis. These two processes require elaborate, controlled cytoskeletal remodeling
to occur. The Plasmodium cytoskeleton comprises the pellicle, which includes the parasite plasma membrane
and a specialized organelle referred to as the inner membrane complex, and the subpellicular network that
constitutes microtubules and a family of intermediate filament-like proteins called alveolins. These structures
together serve to partition cytoplasmic contents during segmentation, confer cell shape and rigidity for daughter
merozoites and developing gametocytes, and provide essential structure support during gliding motility and RBC
invasion. We have recently discovered a novel Plasmodium cytoskeletal protein, PfFIG (Found In Gametocytes)
during our study the basal complex during blood stage P. falciparum infection. My preliminary data demonstrate
that PfFIG is important for asexual replication and is associated with microtubule dynamics in segmenting
schizonts and maturing gametocytes. We do not know, however, the functional role of PfFIG during the
Plasmodium blood stages of human malaria infection. Using inducible knockout (iKO) systems together with
super-resolution and cell viability assays, I will characterize the role of PfFIG (PF3D7_1435600) in P. falciparum
daughter cell segmentation and gametocyte maturation. This will elucidate its unique role in Plasmodium
microtubule dynamics, specifically as it contributes to cell shape and facilitates life stage transitions. Additionally,
I will perform immunoprecipitation and proximity-labeling experiments to map the PfFIG interactome, identifying
proteins of interest for future study and characterization. This research will broaden our understandings of the
core cellular machinery utilized by Plasmodium to carry out its unique life cycle. Specifically, study of
Plasmodium-specific cytoskeletal proteins and their role across parasite life stages will bring us closer to
targeting these proteins with antimalarial drugs.

Public health relevance
PROJECT NARRATIVE The malaria parasite exercises morphological changes to complete its life cycle. We identified a protein which associates with the parasite cytoskeleton in two life stages and is hypothesized to be essential for parasite replication. We aim to characterize its functional role in the blood stages of malaria infection and map its interactions to explore the parasite cytoskeleton and inform the rational design of antimalarial drugs.